OSPEEC BPA TASK AREA 4 ORDER TITLED "HEALTH EDUCATION AND RESEARCH DISSEMINATION PROGRAM(S) FOR LUNG HEALTH"

The objective of this contract is to provide expertise to the NHLBI in strategic, targeted health education and research dissemination program planning for lung-related topics. Efforts will support the dissemination of new research findings, clinical practice guidelines, and educational resources for the public, patients, and community and health professionals.